Lesion extent and seizure propagation pathways across acute infection and chronic epilepsy in an infection induced mouse model

Project Summary
One in twenty-six individuals will develop epilepsy during their lifetime. A major cause of epilepsy worldwide is
viral encephalitis. Infected patients are 16x more likely to develop epilepsy than the general population. Active
infection can provoke seizures in the short term, but also increase the risk of spontaneous, recurrent seizures
post-viral clearance. However, the mechanisms underlying seizures during the acute phase and the development
of chronic epilepsy in the post-viral phase are unknown. The Wilcox lab and collaborators have developed the
only mouse model of viral-induced temporal lobe epilepsy (TLE). C57Bl/6 mice injected with Theiler’s murine
encephalomyelitis (TMEV) recapitulate features of human viral encephalitis: mice exhibit seizures 3-8 days post-
infection (DPI), clear the virus by 14 DPI, and can eventually develop chronic TLE. TMEV infection induces
inflammation, reactive gliosis, and cell death in the hippocampal CA1, which may contribute to acute seizure
development. However, over half of previously infected animals will develop recurrent, spontaneous seizures
long after viral clearance. This suggests differing etiologies between acute and chronically occurring seizures in
TMEV. CA3 neurons are spared by TMEV infection and the amplitude distribution of CA3 mEPSCs varies across
the acute and chronic phase. It is possible that hippocampal damage and consequential inflammation incite
acute seizures, while long-term changes in hippocampal circuitry underlie the chronic seizures. The progression
of TMEV-induced hippocampal lesions and underpinnings of acute vs chronic seizures are gaps in our
knowledge that this proposal aims to address. We will quantify TMEV-induced cell loss and use targeted
recombination in active populations (TRAP) to map the epileptogenic zone and seizure propagation networks
during discrete post-infection timepoints. In Aim 1, we will perform immunolabeling-enabled 3-dimensional
imaging of solvent cleared organs (iDISCO) in TMEV-infected mice at 5 DPI (seizure peak), 14 DPI (after acute
seizures resolve and the virus is cleared), and following the first recorded chronic, spontaneous seizure to
determine the extent and progression of lesions in the acute and chronic phase of TMEV infection. In Aim 2, we
will determine seizure propagation pathways in TMEV-infected mice following seizures in the acute vs chronic
phase by tagging neurons active during seizures at 5 and 14 DPI and the chronic phase with TRAP. Activated
circuitry will then be quantified to compare seizures across the course of TMEV infection and the subsequent
development of TLE. Participation in the proposed training plan and completion of these experiments will
advance my neuroscience training in pursuit of a career as an independent epilepsy researcher. It will also
address crucial questions about epileptogenesis across TMEV infection. These experiments are the foundation
for a future K99 aimed at manipulating the regions, networks, and cell types identified here. It is our hope that
we may discover critical clues to novel treatments for epilepsy patients.

Public health relevance
Project Narrative Viral encephalitis is a major cause of epilepsy that can induce short term seizures and long term, recurrent seizures in infected patients. Despite this public health burden, the etiology between seizures occurring during acute infection and chronically, post-viral clearance is unknown. Elucidating hippocampal and network mechanisms in the TMEV mouse model of viral-induced epilepsy across different timepoints may provide critical clues for manipulating seizure-active circuits and eventually lead to novel patient therapies.